Quantitative Studies of Bacterial Growth Physiology

Project Summary
This project aims to elucidate the physiological origin of the growth inhibitory effect of short-chain fatty acids (SCFA)
such as acetate, propionate, and butyrate on exemplary bacterial species in the gut microbiota. Our preliminary data
indicate that the affectors of SCFA toxicity are a reduction in intracellular pH and an accumulation of the anion form of
these acids in the cytoplasm. A battery of high-throughput methods (quantitative metabolomics, quantitative proteomics,
tRNA aminoacylation arrays, ratiometric fluorescence) are proposed together with classical biochemical approaches to
identify the locations of the growth bottlenecks, and link their growth inhibitory effects quantitatively to the two identified
affectors. These methods will be combined with orthogonal perturbations, one creating “overdose of useless metabolites”
but not affecting intracellular pH, the other reducing intracellular pH but not affecting metabolite abundances, to quantify
the effect of each perturbation on bacterial growth. The results obtained will be used to develop quantitative models that
predict the % growth-reduction for a given SCFA level in the environment.
The above studies will be done for each of the three major SCFAs and for four exemplary gut bacterial species: the best
characterized model organism Echerichia coli, a pathogenic strain of Salmonella Typhimurium, and Bacteroides
thetaiotaomircon and Eubacteria rectale, abundant members from the respective phyla of Bacteroidetes and Firmicutes
which comprise the vast majority of the gut microbiota. We will additionally characterize key mutants that exhibit
reduced SCFA-sensitivity. Comparisons of results for these different species and mutants will provide us with a
comprehensive picture for strategies gut bacteria use to cope with SCFA toxicity, as well as the compromises these
strategies impose on the growth physiology of the organisms in unstressed conditions.

Public health relevance
Relevance Bacterial growth in the anaerobic environment of the human colon leads to the production of copious amounts of short- chain fatty acids (SCFA) as fermentation products. Much recent emphasis in gut microbiome research has been placed on the effects of these SCFAs on the host, but SCFAs also exert significant effects on the gut microbiota itself. By elucidating the inhibitory effects of SCFAs on bacterial growth and different strategies bacteria use to cope with SCFA toxicity, this research will identify and quantify a very important aspect of the gut bacterial community responsible for maintaining the existence of a species and determining its abundance in the gut environment. The knowledge gained in how bacteria resist SCFA toxicity will be valuable to the rationale design of probiotics, by endowing them with unique fitness advantages in the gut environment so that they can close down the niche space of undesirable pathogens.